Trajectories of functional brain network organization from birth to early adulthood as predictors of executive function and psychopathology

PROJECT SUMMARY/ABSTRACT
Executive function (EF) is a critical ability, and low levels of EF are a transdiagnostic risk factor for
psychopathology. EF is composed of dissociable components (e.g., inhibition, updating, shifting) that have
distinct developmental trajectories, and that may be differentially related to psychopathology. Therefore,
characterizing neurocognitive trajectories of distinct components of EF and how they relate to future
psychopathology is a public health imperative. The main goal of this proposal is to identify trajectories of neural
biomarkers that predict EF and psychopathology in a dimensional sample of youth with varying degrees of risk
for psychopathology. Influential theories suggest that transdiagnostic risk for psychopathology is associated with
brain network properties of EF-related networks. Crucially, EF-related brain regions and the EF-related brain
networks that underlie psychopathology change across development, highlighting the need for longitudinal
research to identify when and how neural markers related to EF alter within an individual. To address these
fundamental knowledge gaps, we capitalize on the UNC Early Brain Development Study (EBDS), a unique and
innovative longitudinal study that has followed children, enrolled prenatally, with rich neural and phenotypic data
collected at birth, 1, 2, 4, 6, 8, 10, 12, 14, and 16 years. We propose to conduct novel data collection in 354
participants from this cohort at 18-19 years that includes careful assessment of transdiagnostic psychopathology
and completion of tasks separately probing distinct components of EF while undergoing fMRI scans. Critically,
EBDS is enriched for infants at high risk for future psychopathology (mothers with psychiatric diagnoses; preterm
births), with ~40% of participants considered high risk at enrollment. Thus, we have an unparalleled ability to
chart neurocognitive trajectories from birth through adolescence in a sample of participants that is heterogeneous
in terms of risk for psychiatric outcomes. We leverage theoretical and computational models of the networks
underlying distinct EF components to assess how within-network coherence and integration with other task-
relevant networks changes throughout development, with a focus on the two periods that are most important for
shaping both EF and mental health outcomes: early life and early adolescence. We propose to implement
groundbreaking new methods to use fMRI data to quantify trajectories of neuroplasticity across these two
sensitive periods. Finally, we will examine how interactions from birth between brain development and
environmental context results in increased risk for (or resilience against) psychopathology in emerging
adulthood. The specific aims of this proposal are: 1) to characterize neural and behavioral trajectories of EF from
infancy to emerging adulthood; 2) to establish how neural trajectories relate to functional brain organization
during EF tasks in emerging adulthood; and 3) to determine how and when EF-related neural trajectories diverge
across psychopathology- and environment-related risk levels. This research will provide groundwork that can
lead to early identification and, ultimately, targeted intervention in youth at risk for future psychopathology.

Public health relevance
PROJECT NARRATIVE High levels of executive function (EF) are associated with greater educational attainment, job success, and overall quality of life, while low EF is a transdiagnostic risk factor for psychopathology. This grant leverages and extends a highly unique longitudinal dataset that includes neural data (from birth) and cognitive data (from infancy) through age 16 in a sample enriched for psychopathology and proposes to collect additional new types of data at age 18 that carefully assess transdiagnostic psychopathology and brain function during the performance of EF tasks. By implementing sophisticated longitudinal modeling techniques, methods to quantify neuroplasticity using functional MRI, and brain network analytic tools, this proposal will characterize trajectories of neuroplasticity and functional brain network organization from birth through adolescence, examine how they interact with environmental context to predict executive function and psychopathology in emerging adulthood, and has the potential to identify sensitive periods of brain development that would be optimally targeted by early interventions to reduce risk for future psychopathology and improve long-term outcomes.